On- and Oﬀ-Axis Control of Fibrosis by IL-33 and ST2

Interleukin (IL)-33 and its receptor, ST2, centrally control a remarkable variety of inflammatory and fibrotic
diseases. The IL-33 – ST2 axis relies mostly on the proteolytically mature form of IL-33 cytokine (MIL33), with
less attention usually devoted to the full-length precursor (FLIL33), which is a nuclear factor. The MIL33 – ST2
axis serves diverse functions, among which one of the most prominent is induction of the Th2 phenotype, with
an overt elevation of IL-4, IL-5, and IL-13, leading to eosinophilia, mucus production, and clinical manifestation
of allergy. It remains unclear how the MIL33 – ST2 pathway, while certainly contributing to inflammation and
fibrosis, mediates its proinflammatory and profibrotic effects without always eliciting the Th2 phenotype. Our
preliminary data strongly suggest that IL-33, particularly in its FLIL33 form, may promote inflammation and
fibrosis in an ST2-independent fashion, and reciprocally, ST2 may control inflammation and fibrosis without
requiring IL-33. Thus, we proposed, for the first time, that IL-33 and ST2 may contribute to inflammation and
fibrosis in an “off-axis” fashion. FLIL33 behaves distinctly from MIL33. Some earlier studies suggested that as
a basally and inducibly expressed nuclear factor, FLIL33 modulates inflammatory responses, wound healing,
chromatin stability, and transcriptional regulation in a non-Th2 and receptor-independent manner. Yet, the
pathophysiology of the understudied FLIL33 requires more attention in general and is nearly completely
unknown in fibrosis specifically. Our published and preliminary data suggest that: FLIL33 but not MIL33
potentiates fibrosis without inducing the Th2 phenotype; such distinct effect is partially mediated by ST2 and
also occurs in the absence of ST2; FLIL33 acts so at the levels of both transcriptional and post-transcriptional
regulation; ST2 by itself controls fibrosis; and such regulation involves IL-9.
Based on these findings, the Hypothesis of this study is that in addition to the commonly acknowledged role of
the MIL33 – ST2 axis, FLIL33 contributes to fibrosis both with and without engaging ST2, through both
transcriptional and post-transcriptional regulation, and that ST2 itself may regulate fibrosis through a
mechanism that in part involves IL-9. To challenge this hypothesis, the following Specific Aims will be pursued.
Aim 1 is to define ST2-independent, Th2-independent, post-transcriptional, mechanisms through which full-
length IL-33 potentiates fibrosis. Aim 2 is to define ST2-dependent, Th2-independent, transcriptional,
mechanisms through which full-length IL-33 potentiates fibrosis. Aim 3 is to determine the role of IL-9 in
controlling fibrosis in an ST2-dependent fashion and identify the mechanisms through which both full-length
and mature IL-33 forms attenuate IL-9. A successful completion of these studies will form the basis for better
therapeutic targeting of IL-33 and ST2 is inflammatory and fibrotic diseases. Inflammation and fibrosis are
distinct yet frequently co-occurring processes contributing to a remarkably broad variety of diseases of every
organ and tissue. The inflammatory fibrotic diseases affect the general population; but are particularly
prevalent in Veterans because of their military service-related exposures as well as their often-unhealthy post-
service lifestyles. The central regulatory role of interleukin (IL)-33 as a potent inducer of inflammation and
fibrosis has been solidly established, but the molecular mechanisms of IL-33 biology and pathology are not
fully understood - a limitation that will be addressed by the planned work based on our innovative, paradigm-
shifting, hypothesis. Importantly, both FLIL33 and MIL33 become pathophysiologically engaged under stress,
but IL-33-null mice have no noticeable basal phenotype, suggesting that depletion of IL-33 levels and/or
attenuation of its functions are a safe therapeutic approach. Altogether, the results of this work will uncover
novel aspects of IL-33 biology and form the basis for the development of novel, precise therapeutic modalities
for Veterans with inflammatory and fibrotic diseases.

Public health relevance
Exaggerated and irreversible scarring of body tissues, also known as fibrosis, occurs as a complication of various disease or, in some cases, for unknown reasons. Fibrosis can affect every organ or tissue and, when it develops, diminishes the quality of life and can be even deadly. Fibrosis is particularly prevalent in Veterans as a consequence of their military exposures. There is no cure for fibrosis and the available therapies provide limited to moderate relief. A body molecule called IL-33 works in conjunction with another molecule called ST2 to promote fibrosis. Previous studies focused on this IL-33 – ST2 axis and yielded important information that may allow for therapeutic targeting by innovative therapies. However, not all IL-33-driven features of fibrosis can be explained by this axis’ functioning. Our research has suggested that both IL-33 and ST2 can also contribute to the fibrotic process independently, in an “off-axis” fashion. We will study such independent contributions by IL-33 and ST2 to lay the ground for future development of better therapies against fibrosis.